Research Training in Geriatric Medicine

Project Summary/Abstract
Support is requested for continuation of the University of California, San Francisco (UCSF) Aging
Research Training Program. The principal goal of the Aging Research Training Program is to prepare clinician-
investigators for careers in aging research, particularly within academic Divisions of Geriatric Medicine and in
other clinical disciplines that play a major role in caring for older adults. The program places special focus on
Patient-Oriented Aging Research, although exceptional investigators from all domains of aging research are
welcome.
The Aging Research Training Program aims to develop skills in key areas, including formulation of
research questions, design of observational and experimental studies, techniques for execution of study
design, critical analysis and interpretation of findings, verbal and written scientific communication, and career
development strategies including pathways of entry into successful research careers. The Program has three
concurrent components. The first component is an intensive curriculum in clinical research methods,
culminating in a master's degree. The second component is a series of interactive and “case-based” seminars
related to aging research, including weekly research works-in-progress conferences. The third component is a
mentored research project, which is the cornerstone of the training experience. The program culminates in
presentation of research findings at national scientific meetings, submission of at least two peer-reviewed
research reports for publication, and preparation of a grant application.
The Aging Research Training Program attracts highly qualified MD and PhD candidates. Trainees are
selected for their potential to establish themselves as independent investigators and academic leaders in aging
research. Over the last 5 funding cycles, the program has succeeded in recruiting and retaining outstanding
trainees and progressing fellows into research-oriented faculty positions with a high success rate in obtaining
competitive career development awards. To build on our past success and continue training a next generation
of leaders in aging research, we request a five-year continuation of funding for two postdoctoral fellows in each
of two research training years.

Public health relevance
Project Narrative Training the next generation of clinician-investigators in Patient-Oriented Aging Research is essential to improving care for the growing population of vulnerable older adults. Thoughtful approaches that combine the best of research training alongside close understanding of clinical issues can produce a cadre of investigators who are well-equipped to advance research in this critical area.